Testing an Adapted Diabetes Self-Management Education and Support (DSMES) Digital Health Intervention among Mexican Origin Hispanics to Increase Access and Participation

ABSTRACT
Diabetes is among the top ten leading causes of death among adults 18 years of age and older. Hispanics are
disproportionately represented, having greater than 50% chance of developing type 2 diabetes mellitus (T2DM)
at an earlier age, higher rates of diabetes-related kidney failure, and higher rates of diabetes-related vision loss
than non-Hispanic whites. The cost associated with diabetes in the United States, in 2022, was reported to be
over $412.9 billion dollars with $306.6 billion related to direct cost of the disease (e.g., insulin and diabetic
supplies) and over $160.3 billion associated with indirect cost (e.g., lost work and wages). An effective way of
reducing the risk of diabetes complications, hospitalization, and mortality, is through Diabetes Self-
Management Education and Support (DSMES) interventions; however, these programs are extremely
underutilized and not convenient or accessible to most patients with T2DM. The On the Road to Living Well
with Diabetes (OTR) DSMES program was developed to increase self-management of diabetes. The OTR-
DSMES program is currently offered in-person and is led by community health workers (CHWs). The proposed
project will adapt the in-person bilingual OTR-DSMES intervention into an online digital health version of the
OTR DSMES. We propose three specific aims. Aim 1: Identify barriers and facilitators toward participating in
DSMES interventions among Mexican origin Hispanics (MoHs) who have T2DM and healthcare providers
(HCPs) to inform the adaptation of a digital health intervention (DHI) for diabetes self-management. Aim 2:
Enhance and adapt the On the Road (OTR) to Living Well with Diabetes in-person intervention into a digital
health intervention (DHI). Aim 3: Conduct a three-group randomized study testing the in-person OTR DSMES
intervention against the DHI version of the OTR DSMES and a control group. Our hypothesis is that a DHI
version of the OTR DSMES intervention is as effective as the in-person DSMES and more effective than a
control at increasing diabetes knowledge, intentions and self-efficacy to engage in diabetes self-management
behaviors, and decreasing perceived diabetes stress and HbA1C levels. Upon establishing that the DHI
version of the OTR DSMES intervention is equivalent to in-person delivery, the DHI version could be widely
disseminated to reach broader audiences, including rural populations and home-bound people, thus
addressing sustainability and improving self-efficacy to manage diabetes and subsequently reducing
complications and hospitalizations.